Graduate Training in Biostatistics

DESCRIPTION (provided by applicant) This is a request for an extension of the training program in Environmental Health Statistics at the Harvard School of Public Health. The program prepares pre-doctoral and postdoctoral fellows for research in the application of biostatistics to environmental health. The program will be administered through the Department of Biostatistics, with active participation by faculty members from the Department of Environmental Health and Department of Epidemiology, also located at the Harvard School of Public Health. Trainees will receive high-quality instruction in basic biostatistical theory and methods, such as probability, statistical inference, computing and data analysis. The program will also provide training in specialized topics of particular relevance for environmental applications, such as longitudinal analysis, missing data techniques, statistical genetics and high-dimensional data analysis, and statistical methods relevant to environmental exposure assessment such as measurement error models and spatial statistics. Training will also be provided through applied course work in environmental health and a regular seminar series called Environmental Statistics Seminar Series, where faculty, students, and fellows present their own environmental health-related research. An important focus of training will be the opportunity to collaborate with faculty members on biostatistical research as it applies to environmental health. All trainees will participate in Harvard's program on scientific integrity in the conduct of research as well as professional development workshops focusing on strategies for success in academic settings. Since its inception in 1982, this training program has emphasized strong links to the environmental sciences. In recent years, program trainers have placed particular importance on the recruitment of students from underrepresented minority groups. The focus on interdisciplinary training at the Harvard School of Public Health, as well as its talented and diverse student body and faculty, makes it ideally' suited for a training program in Environmental Statistics. BACKGROUND This is a competing continuation application for a Training Program in Environmental Statistics at the Harvard School of Public Health. The program was started in 1982 and has been continuously supported. The emphasis of program is to train biostatisticians and other quantitative scientists in the theory and practice of statistical science with application to environmental health research. The application is justified based on the increasing need to analyze complex data in environmental health that resulted from the recent advances in data collection technology, and significant interaction of the training program with other funded research projects in environmental health. New over the past five-year funding cycle are two features. In 2003, the Department of Biostatistics entered into an arrangement with the Statistics Department and the Graduate School of Arts and Sciences (GSAS) at Harvard to offer the Ph.D. instead of the S.D. offered by the School of Public Health. This impacts the Training Program by making available the recruiting efforts from the GSAS for qualified Ph.D. candidates; students now qualify for additional scholarships available only to Harvard Ph.D. students (important for under-represented minorities); and this change improves the availability of research mentoring from GSAS faculty in Statistics. Additionally, in 2003 when Dr. Ryan was on sabbatical, Dr. Coull took over as Director of the program. Since her return, Dr. Ryan has been named the co-Director. In 2005, two new faculty members were hired with research interests in environmental statistics. The Training Program is currently administered using an Executive Committee approach (Dr. Coull as Director, Drs. Ryan and Lin serve as co-Directors, with Dr. Paciorek involved in all administrative decisions).